Nonhormonal contraceptive intravaginal ring based on high valency anti-sperm antibody constructs

Summary
Nearly half of all pregnancies in the U.S. are unintended, and most occur in women who are not using
contraceptives. There are diverse reasons for not using contraceptives; one common reason is that many
women have a strong aversion to using exogenous hormones due to real and perceived side effects. It is likely
that contraceptive use and satisfaction would substantially increas if there is a non-hormonal, user-controlled
contraceptive method that does not require coitally-timed actions nor daily dosing. Such product does not
currently exist. We believe we can create such a non-hormonal contraceptive based on an intravaginal
ring (IVR) releasing a sperm-binding antibody (Ab) that agglutinates and traps sperm in mucus, thereby
preventing sperm from reaching the egg. Topical passive immunization by direct delivery of anti-sperm Ab
to the vagina was validated in animal models in the 1980s-1990s, and directly overcomes the variable
intensity and uncertain reversibility of contraceptive vaccines. However, this strategy was not practical until
recently due to the high costs of Ab production. Given the remarkable advances in bioprocessing that have
greatly reduced the manufacturing costs of Ab, we believe the time is now ripe to develop an IVR for
sustained passive immunization of the vagina with a potent anti-sperm Ab. Our approach is based on a well
characterized and validated antigen target present on human sperm, and we have a fully human mAb that
binds this antigen and agglutinates within seconds all human sperm, and does so in over 100 semen samples
from diverse semen donors. We further increased sperm-agglutination potency by engineering novel high-
valency constructs comprising six Fab domains (i.e. 4 additional Fabs linked to the parent IgG molecule) and
eight Fab domains (6 additional Fabs); we term these constructs MM006 and MM007, respectively. In
addition, we enhanced the safety profile by incorporating Fc mutations that reduce binding to FcgR,
mitigating the likelihood of developing immunity against sperm. By incorporating multiple Fab domains while
preserving Fc, we substantially improved agglutination speed and potency, while retaining the stability and
ease of commercial manufacturing of parent IgG. Since the antigen target is present only on human sperm,
this precludes direct evaluation of contraceptive efficacy in animals. Instead, our goal in the R61 phase is to
select between MM006 and MM007, formulate the mAb into a capsule-IVR, and demonstrate the IVR can
sustain effective contraceptive concentrations and assess local distribution and toxicity in the sheep vagina
model, which is anatomically similar to the human vagina. If we meet the R61 milestones, we will focus the
R33 phase on developing cGMP-compliant manufacturing process for the selected mAb, culminating in Master
Cell Banked CHO cells (essential part of IND filing) and GLP tox study in rats. If successful, the work will
strongly support clinical evaluation of our non-hormonal contraceptive IVR that could address a significant
unmet need in the marketplace, and lay the foundation for multifuntional IVRs that also protects against STIs.

Public health relevance
Narrative Statement In the U.S., nearly half of all pregnancies are unintended, incurring a cost burden of over $20B to the federal and state governments each year. Here, we will develop our capsule-intravaginal ring (IVR) technology for sustained release of an engineered sperm-binding antibody for non-hormonal contraception, evaluate its potency in human genital secretions and in the sheep vaginal model, and engage in further preclinical development in preparation for eventual clinical evaluation. Successful completion of this project will enable us to quickly begin clinical development of a non-hormonal contraceptive IVR.